Core D In vitro Screening

Abstract
The microbial In Vitro Screening (IVS) Core will provide comprehensive susceptibility testing
encompassing a range of assays for candidate compounds of the five projects. The projects
represent various stages in development and require individual consideration. However, a
common thread through all 5 projects is the requirement for whole cell screening. The resources
and expertise of the IVS Core include macrophage infection model and intracellular susceptibility,
concentration-dependent killing versus time-dependent killing, small colony variants, anti-biofilm
efficacy, serum shift experiments, stationary phase or “one hundred day old” cultures, resistant
mutant generation and analysis, and drug combination analysis. Drug response relationships to
assess mutant formation/prevention and other advanced analysis are also available. Compound
purity will be confirmed working in conjunction with the Medicinal Chemistry Core (Core B). Data
conformity and storage will be handled and shared using the Collaborative Drug Discovery, Inc.
software program (see Data Sharing). The organisms in the Screening Core’s collection include
twenty-eight species of pathogens. The laboratories of Dr. Connell and Dr. Barry Kreiswirth
(PHRI) provide extensive collections of clinical strains, well characterized for antibiotic resistance,
assembled in collaboration with private, public and VA hospitals in the New York/New Jersey
metropolitan area, as well as hospitals throughout the world, that will serve in later stages of the
project to define resistance profiles. BSL2, BSL3 and Select Agent BSL3 laboratories are
provided for the safe use of this extensive strain collection. The team assembled to carry out
these in vitro assays has a combined experience of over 65 years in bacterial drug discovery and
analysis of antibiotic susceptibility and resistance. The group's medium throughput experience
with high precision and fast turnaround is a significant and essential contribution to the overall
project’s success.
!